SUPPORT SERVICES FOR OVERSIGHT OF SEER*DMS MIGRATION FOR ALL THREE (3) CALIFORNIA SEER REGISTRIES TASK ORDER AGAINST IDIQ CONTRACT SURVEILLANCE, EPIDEMIOLOGY, AND END RESULTS (SEER) PROGRAM, POP: 07/1

All SEER Core registries are required by contract to migrate to the SEER*DMS system for the collection and abstraction of cancer cases. There are three regional registries in California that are SEER Core registries but have not yet migrated to SEER*DMS. CDPH is the grantholder within the state of California and the regional registries are grantees to CDPH. In order to move forward with DMS migration, NCI entered into a contract with CDPH to enable this migration effort to begin.